Effects of Advanced Glycation Endproducts on Type 2 Diabetic and Fragility Fractures

Abstract
Bone fractures contribute significantly to healthcare cost affecting the quality of life. Clinically, fracture risk
can be predicted by dual x-ray absorptiometry (DXA) or the fracture risk assessment (FRAX) tool. Because
type 2 diabetes (T2D) patients exhibit high bone mineral density (BMD), both tools fail to correctly predict
fracture risk, leading to a significant increase of fragility fractures in diabetic subjects. Therefore, there is a
need to investigate how modifications in collagen and other organic components in bone can predict
diabetic fractures. Pentosidine (PEN), a fluorescent Advanced Glycation Endproduct (AGE) that forms in
bone by reaction between sugars and proteins, is the only established marker of bone fragility. However, it
does not consistently predict T2D and fragility fractures. Here, for the first time in bone, we demonstrate the
presence of carboxymethyl-lysine (CML), a non-fluorescent glycoxidative AGE, and present a technique to
measure it. We show that it forms in abundance in bone and is highly correlated to loss of bone toughness.
We demonstrate that, in contrast to other AGEs, CML is upregulated >60% in T2D human bone compared
to their age-matched controls. We then provide evidence that CML promotes formation and growth of
additional hydroxyapatite (HA) crystals, similar to human T2D condition, and forms a ‘molecular link’
between the organic and inorganic components of bone (collagen-HA interface) impairing bone quality. Our
overall hypothesis is that CML is a ‘new and relevant’ biomarker of T2D fracture that captures the
effects of both hyperglycemia and oxidative stress in bone and explains the susceptibility of bone to
fracture in T2D. Using an obese and a non-obese mouse model of T2D, that mimic both causality and
impact of human T2D on bone, we provide evidence that T2D increases AGEs, with CML explaining bone
fragility. Similarly, using data from the Health, Aging and Body Composition (ABC) study we show that
higher serum CML levels are associated with increased risk of incident clinical fractures in T2D,
independent of BMD. Thus, our overall goal is to establish CML as a new and relevant biomarker of bone
fragility and determine how it contributes to bone fragility in T2D. Using in vitro models, ex vivo human
cadaveric tissue, in vivo mouse models of obese and non-obese T2D, and existing data from the Health
ABC study we will pursue there aims: Aim 1: Establish NEG conditions for enhanced formation of CML over
other AGEs and determine the mechanism(s) by which it reduces energy dissipation in bone; Aim 2:
Determine the contribution of CML and other AGEs to alterations in bone matrix and energy dissipation in
human T2D vertebrae and cortical and cancellous bone from hip fracture patients; and Aim 3: Validate CML
as a biomarker of T2D bone fragility and establish its association with hyperglycemia and oxidative stress.
Our findings will provide a new understanding of the mechanism and the effects of CML and other AGEs on
bone fractures leading to new strategies to predict, manage and mitigate T2D and fragility fractures.

Public health relevance
Project Narrative Bone fractures in type 2 diabetes cannot be accurately predicted by current bone density-based clinical tools as T2D patients exhibit normal to high bone mineral density. This project will establish Carboxymethyl-lysine (CML) as a new biomarker of T2D fracture and determine how the oxidation and glycation processes, associated with diabetes under obese and non-obese conditions, impact accumulation of CML and other Advanced Glycation Endproducts (AGEs) and enhance bone fragility. The results will provide new strategies to diagnose, treat and mitigate T2D and fragility fractures.